Targeting endogenous retrovirus Gag genes for biomarker development in type 1 diabetes

Project Summary:
Approximately 5-8% of the genome consists of remnants of ancient retroviruses that were integrated into the
host genome through germ line infection. These retroviruses are known as endogenous retroviruses (ERVs). Some ERV
proviruses have a complete or partial genome structure and can produce viral antigens and pseudo-viruses that interact
with the immune system. Human endogenous retroviruses (HERVs) have been linked to autoimmune diseases such as
type 1 diabetes (T1D). In our study, which focuses on the relationship between ERVs and autoimmunity using deep
sequencing, we unexpectedly discovered a connection between the number of sequence variants encoding an open
reading frame (ORF) of the ERV gene Gag and disease progression in both a non-obese diabetic (NOD) mouse model
and human T1D patients. Abnormal sequence variants of ERV Gag genes could potentially be associated with increased
autoimmune activation. In this study, we will use deep sequencing to measure the Gag gene variants with ORFs as
biomarkers. The experiments aim to further investigate NOD mice and various T1D-susceptible and -resistant mouse
strains in order to understand the mechanism that regulates the expression of these gene variants. Furthermore, we will
expand the study on T1D patients by including autoantibody-negative and prediabetic controls to validate whether this
sequencing-based biomarker could be used to screen high-risk children, stage pre-diabetic patients, and predict the onset
of diabetes.

Public health relevance
Project narrative Human endogenous retroviruses (HERVs) have been found to be involved in the development of in type 1 diabetes (T1D). Our research has uncovered a link between the expression of a specific HERV gene called Gag and its various sequence variants with T1D. Based on this finding, we propose to use deep sequencing technology to accurately measure these sequence variants and utilize these measurements as biomarkers for predicting the risk of developing T1D, as well as to monitor the progression of the disease.